Optimizing singlet oxygen dosimetry for photodynamic therapy (PDT)

Optimizing Singlet Oxygen Dosimetry for Photodynamic Therapy (PDT)
Abstract
The overall objective of this project is to optimize clinical singlet oxygen (1O2) dosimetry (SOD) via three
complementary and competing technologies: time-resolved singlet oxygen luminescence dosimetry (TSOLD),
multispectral singlet oxygen luminescence dosimetry (MSOLD), and singlet oxygen explicit dosimetry (SOED).
The TSOLD instrument is optical fiber-based and achieves ultralow noise detection via infrared time-correlated
single-photon counting. It can be used before and after PDT to measure cytotoxic 1O2 concentration ([1O2])
generation in tumor based on its 1270 nm luminescence emission, since it utilizes a short (ns) pulsed laser for
1O2 excitation that is independent of the PDT treatment laser. The recently developed MSOLD instrument
measures the luminescence spectrum of singlet oxygen excited by the treatment light, it is thus capable of
monitoring [1O2] during PDT without interfering with the treatment. However, unlike TSOLD, MSOLD may
introduce additional uncertainty in [1O2] due to a phosphorescence background orders of magnitude larger than
the singlet oxygen signal. The SOED instrument can be used in-vivo during PDT in real-time to measure reacted
1O2 generated by the treatment light based on explicit measurement of the light fluence rate, tissue oxygen
concentration, and photosensitizer concentration. The TSOLD or MSOLD signals will be used as an input to the
SOED system to make it more robust to account for the local oxygen microenvironment. Here, the immediate
clinical translation is to compare and determine the most suitable combination of the three technologies for SOD
by measurements at multiple sites in patients undergoing intrapleural PDT for malignant pleural mesothelioma,
which has shown significant potential in Photofrin-mediated clinical trials at UPenn. In addition, comparison will
be made in photosensitizer solutions, tissue-simulating phantoms, and tumors in vivo under well-controlled
conditions across a wide range of treatment conditions. Correlation of the tumor response with the1O2
measurements will be evaluated for three clinical photosensitizers (Photofrin, BPD, and ALA) in preclinical
models. The SOED instrument will be used at the same time and locations to calculate the “explicit” light-drug-
oxygen dose parameters as well as the tissue optical properties. The latter will be used to correct the measured
1O2 signal for light attenuation in order to calculate, the absolute concentration of the cytotoxic agent. The explicit
dose parameters will be used as inputs for SOED in an established macroscopic biophysical model to predict
the instantaneous and cumulative singlet oxygen concentration ([1O2]) for comparison with TSOLD and MSOLD
results, respectively. The outcome of this project will be the determination of the optimal combination
(TSOLD/MSOLD/SOED) for SOD in an ongoing PDT mesothelioma clinical trial under clinically-relevant
conditions. We hypothesize that quantitative SOD will be significantly more predictive of PDT efficacy than the
explicit or implicit (photobleaching-based) techniques used at present. Moreover, we hypothesize that the
optimized SOD system will give real-time feedback so that treatment can be personalized.

Public health relevance
Public Health Relevance Statement: Photodynamic therapy (PDT), in combination with surgery, offers a potential locally curative treatment and has been demonstrated in clinical trials, including in malignant mesothelioma, to substantially prolong patient survival. In this translational project we will optimize singlet oxygen dosimetry instruments for direct quantitative measurements of the major cytotoxic agent (excited-state singlet oxygen) generated in PDT, which could significantly improve the accuracy and hence efficacy of this modality, both for this particular clinical application and more generally in other tumor sites. Being fiberoptic based, the technology will be suitable for implementation in any tumor site that is accessible to PDT (interstitial, endoscopic, intraoperative).